SPAK-NKCC1 complex and the blood-CSF barrier dysregulation in VCID

Project Summary
The choroid plexus (ChP) modulates brain homeostasis through its multifunctional roles, including secretion
of the cerebrospinal fluid (CSF) and forming the blood-CSF barrier via tight junctions (TJs) and adheren
junctions (AJs) at the choroid plexus epithelial cells for gating circulating immune cell entry into the CSF. The
Ste20-related serine-proline-alanine rich kinase SPAK in the ChP epithelial cells emerged as a central player
in mediating immune cell signaling as well as modulating the secretion of CSF [via phosphorylation of the
secretory ion transporter Na-K-Cl cotransporter protein (NKCC1)]. Activation of SPAK-NKCC1 protein
complex in the ChP has been reported to contribute to infectious hydrocephalus, hemorrhagic hydrocephalus
and brain inflammation. Moreover, ChP dysfunction is suggested as a key contributor to Alzheimer's disease
(AD) pathogenesis. Breakdown of the blood-CSF barrier in AD brains has been associated with more
pronounced changes in proinflammatory phenotype of myeloid cells, which were detected in both the ChP
and brain parenchyma. Suppressed CSF secretion and turnover have also been observed in AD brains.
However, the pathological mechanism of blood-CSF barrier dysfunction in AD/VCID brains remains
unknown. The potential role of SPAK signaling complex in the ChP structural impairment and
neuroinflammation in non-infectious, chronic sterile brain disease conditions has not been defined. To fill the
knowledge gap, we conducted initial study using a mouse vascular contribution to cognitive impairment and
dementia (VCID) model induced by the bilateral carotid artery stenosis (BCAS). We observed the following
new findings (Prelim data): 1). BCAS-mediated chronic cerebral hypoperfusion caused abnormal
accumulation of TJ proteins, which was accompanied with phosphorylatory stimulation of SPAK, NKCC and
NF-κB in the ChP epithelial cells; 2). These changes are associated with impaired blood-CSF barrier integrity,
as evidenced by ChP infiltration of immune cells; 3). Pharmacological blockade of SPAK with its potent
inhibitor ZT1a in the BCAS mice attenuated the ChP damage and improved neurological function. These
findings led us to hypothesize that BCAS-induced pathological stimulation of the epithelial SPAK signaling
cascade plays a role in disruption of the blood-CSF barrier, choroidal route of leukocyte infiltration, and ChP
dysfunction. We will investigate underlying cellular mechanisms in three Specific Aims: 1. Investigate
whether BCAS causes disruption of the ChP epithelial cytoarchitecture and polarity. 2. Investigate whether
SPAK- and NF-κB-dependent transcriptome changes drive dysregulation of the ChP epithelial
cytoarchitecture and polarity. 3. Determine whether BCAS alters the ChP volume and CSF secretion. In
summary: completion of this study will provide new knowledge about the cellular and molecular mechanisms
underlying ChP dysfunction and leukocyte invasion in VCID and will shed light on ChP SPAK signaling
cascade as a novel therapeutic target for blood-CSF barrier impairment.

Public health relevance
PROJECT NARRATIVE The choroid plexus (ChP) modulates brain homeostasis through secretion of the cerebrospinal fluid (CSF) and functions as the blood-CSF barrier in gating circulating immune cell entry into the CSF. Alzheimer's disease and dementia subjects displayed loss of the blood-CSF barrier integrity and altered CSF composition. This proposal will use mouse models of vascular dementia to investigate the underlying molecular and cellular mechanisms of the ChP blood-CSF barrier damage and to identify therapeutic targets.